Center for comprehensive proteogenomic data analysis

Project Summary
Proteogenomics involves the integrative multi-omic analysis of genomic, transcriptomic, proteomic and post-
translational modification data produced by next-generation sequencing and mass spectrometry-based
proteomics. Several publications by the Clinical Proteomic Tumor Analysis Consortium (CPTAC) and others
have highlighted the impact of proteogenomics in enabling deeper insight into the biology of cancer and
identification of potential drug targets. Integrative analysis of multi-omic data requires the deployment of
complex algorithms and data processing techniques, which are generally inaccessible to scientists without a
background in bioinformatics and computational biology.
Our proposed center for comprehensive proteogenomic data analysis will encapsulate a comprehensive
set of analysis methods in a platform that will be (i) simple to use (ii) flexible (iii) automated, facilitating the
routine application to all CPTAC proteogenomic datasets as they become available, and (iv) able to
incorporate new methods with minimal effort. We will leverage PANOPLY--a cloud-based platform for
automated and reproducible proteogenomic data analysis--as the foundation, with specific, carefully chosen
algorithms targeted for addition to provide an expansive set of analysis capabilities that can be easily
harnessed to provide a rapid and extensive baseline analysis for proteogenomic studies, leading to many
disease specific hypotheses that can be explored further using additional computational and wet-lab
experiments.
Our collection of tools, algorithms and interactive reports will enable unprecedented, automated and integrative
systems-biology level analyses of proteome, post-translational modification and metabolomic data combined
with genomic data for individual disease cohorts and pan-cancer analysis across cohorts, leading to deeper
understanding of cancer biology and enabling identification of therapeutic targets and disease/prognostic
biomarkers.

Public health relevance
Project Narrative Genetic alterations in human cancer have been systematically studied over the past decade, but the impact of a majority of these changes on the proteome—the functional end of the genome—are poorly understood. In this project we will implement a large-scale automated data analysis platform that will integrate clinical, genomics and mass spectrometry-based proteomics data from the same samples/tumors, and bring to bear novel big-data algorithms and analysis methods to shed new light on the biology of cancer, the response and resistance to drug treatments and, importantly, help to identify new targets for therapeutic intervention.